Interdisciplinary Cerebrovascular Diseases Training Program in South America

The Overarching Goal of this proposed competing renewal of the Interdisciplinary Cerebrovascular Training
program in South America (ICTuS) is to continue building a cadre of Peruvian physicians to reduce the morbidity
and mortality of cerebrovascular disease in Peru through: a) identifying environmental, host and lifestyle factors
associated with increased risk for cerebrovascular disease, b) implementing treatment and prevention programs
to reduce these risks, c) enhancing post-stroke rehabilitation therapies for persons with stroke and their
caregivers, and d) collaborating with academic institutions and hospitals to adapt policies to address population-
level stroke care needs identified through this program. To achieve this goal, we propose the following specific
aims: #1. Enhance investigation and management of cerebrovascular disease and post-stroke rehabilitation in
Peru through workshops, didactic courses and Masters degree-level training in research methodology with
clinical preceptorships for young Peruvian physicians; #2. Support mentored clinical research projects in Peru
for all medium and long-term physician trainees to obtain data for thesis work, publications and future grant
applications in the fields of cerebrovascular and post-stroke rehabilitation; and #3: Improve quality of stroke care
and post-stroke rehabilitation in Peru through implementation science, quality assessment and quality
improvement. Over this second five-year training period, we propose to emphasize implementation science and
continuous quality improvement – which will be included as topics of workshops in Peru, didactic classes for
medium and long-term trainees in Seattle, and as topics for mentored thesis projects. In addition, through the
pending accreditation of the first stroke training fellowship in Peru – spearheaded by prior ICTuS trainee Dr.
Carlos Abanto, we anticipate offering all of our proposed research training activities to new Peruvian stroke
fellows – increasing the emphasis and integration of research into the stroke fellowship and increasing our
candidate pool for training in Peru and Seattle. Our specific aims will be addressed through a combination of
short, medium and long-term training, with an emphasis on master's degree training at the Universidad Peruana
Cayetano Heredia (UPCH) and the University of Washington (UW) and three-month Comprehensive training in
epidemiologic research methods at the UW with practical experience in stroke management and rehabilitation
medicine. We also propose short training workshops in implementation science, cerebrovascular and chronic
diseases epidemiology, manuscript and grant preparation, and responsible conduct of research; mentor training
courses will be held concomitantly with workshops. The greatest strengths of this proposed training program
are the development of the first stroke fellowship in Peru that is undergoing accreditation and will provide an
increased stream of applicants for our proposed training activities; world-renowned clinical researchers,
neuroepidemiologists, and stroke experts in Seattle and Peru who will serve as mentors; and well-developed
study sites in Peru.

Public health relevance
This proposed continuation of our ICTuS research training program would train Peruvian neurologists and physiatrists how to design and conduct clinical and implementation science research to better understand the causes of stroke in Peru, provide practical training in management and research in acute stroke, stroke prevention and rehabilitative methods, and improve the quality of care provided to stroke patients to reduce neurologic disability following stroke and improve resources available for preventing stroke.